Longitudinal Changes in Weight and Biology in the Pregnancy-Postpartum Period and Subsequent Cardiometabolic Risk

Pregnancy marks a period of extreme physiological change as the maternal immune, endocrine, and metabolic
systems rapidly adapt to sustain the growing fetus. It is conventionally assumed that these pregnancy-induced
changes (e.g., elevated lipids, insulin resistance, weight gain) reverse by 6-months postpartum. Yet, evidence
suggests that for some women physiological changes persist and may confer long-term risk of chronic
diseases such as cardiovascular disease (CVD). We have demonstrated, for example, that inflammatory
markers that confer risk for CVD may stay elevated above pre-pregnancy levels beyond 6-months postpartum.
Thus, characterizing weight and biological changes across pregnancy-postpartum, predicting the women at
risk for adverse cardiometabolic profiles, and identifying modifiable factors that mitigate these profiles offer
opportunities to create targeted interventions to prevent future chronic disease. To improve our understanding
of the nature of biological changes in the pregnancy-postpartum period that may predict cardiometabolic risk,
we propose a cost-efficient longitudinal study extending from the first trimester through 3 years postpartum that
capitalizes on the infrastructure of an ongoing pregnancy cohort (R01 HD083369). The parent study, which
focuses on maternal prenatal biology as it relates to child health outcomes, is currently recruiting a
socioeconomically and racially diverse sample of 290 first trimester pregnant women. Blood, saliva,
anthropometry, and psychosocial, lifestyle, and health data are collected across pregnancy in the parent study.
We will leverage the existing infrastructure and data collected as part of the parent study and expand that
existing framework by (1) assessing additional biomarkers from banked prenatal maternal samples and
obtaining new maternal biological samples at 6, 12, and 36 months postpartum; (2) examining how maternal
weight, immune, endocrine, and metabolic biomarkers from the first trimester through 12 months postpartum
predict subsequent cardiometabolic risk in the mother, and (3) identifying modifiable maternal health behaviors
that may mitigate adverse cardiometabolic health outcomes. Our over-arching premise is that the immune,
endocrine, metabolic, and weight changes of pregnancy can be long-lasting and contribute to an adverse
cardiometabolic profile that increases long-term chronic disease risk. The aims are to: (1) identify maternal
weight profiles in the pregnancy-postpartum period that predict adverse cardiometabolic risk profiles three
years postpartum; (2) describe immune, endocrine, and metabolic biomarker profiles in the pregnancy-
postpartum period, and determine their associations with cardiometabolic risk; and (3) determine how
modifiable health behaviors are associated with weight and biomarker changes in the postpartum period and
predict cardiometabolic risk. The significance of this project is high given the increasing rates of obesity in
pregnant women and the need for targeted, biologically and psychosocially informed treatments to prevent
cardiometabolic disease in women.

Public health relevance
This project will examine maternal weight, immune, endocrine, and metabolic changes from early pregnancy until 3 years postpartum to determine the extent to which the usual metabolic changes of pregnancy persist into the postpartum years. We will also assess how psychosocial and behavioral factors such as breastfeeding and stress predict or change the cardiometabolic risk of women after pregnancy. The results of this project will help to inform targeted interventions during the pregnancy-postpartum period, with the goal of reducing downstream cardiometabolic disease in women.